Administrative & Mentoring Core

ADMINISTRATIVE & MENTORING CORE – PROJECT SUMMARY
The Administrative and Mentoring core (Admin Core) will be responsible for the leadership, integration and
successful operations of the COBRE in Neurodevelopment and Its Disorders (CNDD). The Core is directed by
Christopher Cowan, PhD, CNDD Program Director, with assistance from Laura Carpenter, PhD, and Stephen
Tomlinson, PhD, CNDD Associate Directors, who form the Executive Committee along with the CNDD Core
Leaders and Primary Mentors. An Internal Advisory Committee of eight senior institutional leaders and an
External Advisory Board of five eminent scholars will provide objective oversight, evaluation, and strategic
interactions to optimize the Center’s impact. The Specific Aims of the Admin Core are: 1) Leadership and
Accountability; 2) Mentoring and Faculty Development; 3) Pilot Projects Program; 4) Biostatistical Support; and
5) Center Evaluation.